MATCHES: Making Telehealth Delivery of Cancer Care at Home Effective and Safe

Project Summary/Abstract
The MATCHES (Making Telehealth Delivery of Cancer Care at Home Effective and Safe) Telehealth Research
Center aims to build the evidence base necessary to establish best practices for telehealth-enabled cancer
care. The overarching goal of the Center is to create a research hub that generates evidence, trains
investigators, and develops the research methods required to ignite the field of precision cancer care delivery.
Prior work demonstrates that oncology-focused telehealth can achieve favorable outcomes, but large-scale
trials have been limited to specific contexts like palliative care or survivorship. Adoption has been constrained
by restricted reimbursement. The MATCHES Center will help remediate this evidence gap by executing
prospective trials, conducting observational analyses, and training transdisciplinary researchers. Our research
theme focuses on the integration of multi-layered data from telehealth platforms, patient portals, mobile
tracking devices, and the electronic medical record to develop analytic methods that support personalized
care. We aim to develop a new paradigm in oncology—precision delivery—with the ultimate goal of matching
individual patients with the most beneficial combination of clinic-based or telehealth-supported home-setting
care at the appropriate time—all based on the totality of dynamically available data. We will accomplish this
goal by applying data science methods—including nimble trial designs and machine learning—that have had
limited application to telehealth to date. By establishing a research hub that nurtures investigators across
disciplines and provides training, tools, data, analytic methods, and venues for sharing knowledge and building
partnerships, we expect to accelerate progress in the science of care delivery. Our specific aims are 1) to
conduct impactful pragmatic trials of telehealth in oncology, 2) to analyze a large existing cache of
multidimensional observational data characterizing telehealth utilization and outcomes, 3) to train investigators
and equip them with the skills necessary to innovate within an evidence-based framework, and 4) to integrate
telehealth with other data streams and create and apply analytic methods to transform the field of precision
care delivery. An Administrative Core will coordinate activities and engage feedback from internal and external
stakeholders—including patients and the oncology workforce. Our Clinical Practice Network serves as an
innovation laboratory and comprises 7 outpatient clinics in NY and NJ with a shared informatics ecosystem
including telehealth capacity, digital monitoring, and a highly trafficked patient portal. This will enable us to
launch and execute a large pragmatic trial comparing in-person care to telehealth, with resources designed to
support home-based care using a cluster-randomized design. The Research & Methods Core will support the
Center by applying data science methods to extract and synthesize insights from telehealth and other data
streams to develop methods relevant to advancing precision cancer care delivery and the goals of equity,
efficacy, and efficiency to create an optimal experience for people being treated for cancer.

Public health relevance
Narrative The COVID-19 pandemic forced explosive growth of telehealth—synchronous virtual visits between patients and clinicians—under crisis conditions, but it is now essential to generate robust evidence regarding when telehealth’s benefits outweigh its risks in oncology practice; how to ensure that telehealth provides highly effective, efficient, and equitable care; and how to identify best practices for telehealth implementation. The MATCHES (Making Telehealth Delivery of Cancer Care at Home Effective and Safe) Telehealth Research Center will bring together investigators and trainees from multiple disciplines to meet these challenges by 1) conducting pragmatic and pilot trials across our integrated network of outpatient oncology practices; 2) leveraging our substantial cache of observational data to build the evidence base necessary to establish best practices for telehealth-supported cancer care; and 3) to investigate concerns about safety and addressing the risk of exacerbating disparities in access to high quality healthcare. Our Center’s theme focuses on developing data science methods to integrate telehealth data with other complex data streams to measure outcomes and quality of care.